Investigating Senolytic Properties in Pulmonary Rehabilitation and Metformin in COPD Exacerbations (INSPIRE-COPD-E).

PROJECT ABSTRACT
In older adults (age ≥ 65), chronic obstructive pulmonary disease (COPD) exacerbations are a major health
problem, leading to recurrent hospitalizations and early death. Available treatments are often ineffective, as 50%
of patients on maximal therapy continue to have exacerbations. To develop better therapies, we must first identify
the biological mechanisms underlying COPD exacerbations. One such possibility is systemic immune system
dysfunction, resulting in impaired host immunity leading to greater susceptibility to respiratory viral infection, the
most common cause of COPD exacerbations. Older adults with COPD demonstrate accelerated age-related
decline in immune system function (e.g., accelerated immunosenescence) characterized by greater levels of
senescent T-cells, which are functionally inactive but secrete pro-inflammatory cytokines termed senescence
associated secretory phenotype (SASP). Thus, to decrease the likelihood of COPD exacerbations, we need to
identify therapies that target cellular senescence — senotherapeutics — under the assumption that
senotherapeutics improve immune response, which in turn increases protection against respiratory infections
and lowers COPD exacerbation risk.
This project has been designed to evaluate two senotherapeutic approaches: pulmonary rehabilitation (PR) and
Metformin. First, PR is a non-pharmacological, supervised, structured exercise intervention, which is a safe and
effective treatment to prevent COPD exacerbations in older adults. In healthy older adults, exercise interventions
reduce senescent T-cells, leading to proliferation of naïve T-cells resulting in an improved immune response. I
hypothesize that PR is effective in preventing COPD exacerbations, because it leads to removal of senescent
T-cells, which leads to reduction in SASP levels, proliferation of naïve T-cells, and, by extension, improvement
in immune response. I will use PR as a model-system to determine whether changing the ratio of senescent to
naïve T cells in favor of naïve T cells and reducing SASP levels can serve as a viable senotherapeutic approach
for COPD exacerbation prevention. Second, even though PR is an effective approach to prevent COPD
exacerbations, participation in PR among older adults with COPD is low due to numerous barriers. Therefore, in
this project I will evaluate whether Metformin, a treatment for diabetes, which is considered a promising
gerotherapeutic medication due to its’ low cost and impact on numerous hallmarks of aging, is safe and feasible
among older adults with COPD without diabetes. If I confirm safety and feasibility of Metformin, I will be well
positioned to test the effectiveness and safety of Metformin to prevent COPD exacerbations in a future R01
proposed phase II clinical trial. Together, this project has great potential to advance the fields of COPD and
geroscience. This project will also allow me to complete a structured, personalized career development plan and
transition into academic independence as a leader in geriatric pulmonology.

Public health relevance
PROJECT NARRATIVE COPD exacerbations are a major health problem in older adults, which currently do not have effective preventative treatments due to poorly understood mechanisms underlying COPD exacerbations. This project will use pulmonary rehabilitation, a safe and effective program to prevent COPD exacerbations, and Metformin, a medication for diabetes with a wide array of geriatric benefits, to determine modifiable biological targets to prevent COPD exacerbations. In addition, the safety and feasibility of Metformin in older adults with COPD without diabetes will be evaluated in preparation for a future clinical trial using Metformin to prevent COPD exacerbations.